Clinical Core

The purpose of the Clinical Core is to provide critical support for individual projects, including (1) assistance with recruitment and screening of normal subjects, (2) the identification of patients with specific autonomic disorders, (3) nursing and paramedical support for the performance of individual studies, and (4) the management of clinical resources (equipment and space) in a cost-effective manner. Shared study rooms and equipment permit flexibility and will maximize the availability of computer data acquisition systems, and specialized equipment. The Clinical Core supports state-of-the-art techniques for the functional assessment of autonomic function in man. The Core has implemented new methods and techniques relevant to the study of cardiovascular regulation, and continues to develop novel approaches to the analysis of complex biomedical signals, which can be now applied to support individual projects.

Public health relevance
RELEVANCE (See instructions): The purpose of the Clinical Core (Core B) is to provide shared resources, equipment, techniques and support personnel to all investigators in this Program Project Grant. This is more cost-effective than having each project develop their own methodologies, and assures greater quality control.